Scalable single-cell workflow for multiomic analyses of chromatin interactions, accessibility, gene expression and cell surface proteins to unravel mechanisms of cellular diversity

Scalable single-cell workflow for multiomic analyses of chromatin interactions, accessibility, gene
expression and cell surface proteins to unravel mechanisms of cellular diversity
Arima Genomics
Project Summary/Abstract
All cells in the human body carry the same DNA sequence and yet individual cells are highly diverse in identity,
morphology, proliferation, and function, leading to enormous heterogeneity in the context of tissues, organs, and
organisms. Individual cells achieve this diversity via unique gene regulatory programs – where in, unique sets of
regulatory elements (REs) precisely instruct each cell which genes to express and when. Mapping such gene
regulatory programs are central to molecular biology and genomics, as mis-regulation is a major cause of disease
– mapping not only helps in diagnosis but also enables therapies that can intervene and correct mis-regulation.
Single cell ATAC sequencing (scATAC) has emerged as the popular mapping assay to delineate REs unique to
each cell. When scATAC is performed alongside single cell RNA sequencing (scRNA), the researcher has
access to both REs and gene expression, allowing them to obtain unprecedented insight into the gene regulatory
programs of living cells. There is only one problem – there are often multiple REs in the neighborhood of a gene
and without the ability to link specific REs to its target genes, a mechanistic view of gene regulation is lacking,
limiting our ability to enable precise diagnosis and drug discovery programs.
High throughput chromatin interaction capture assay and sequencing (HiC) presents a three-dimensional view
of the genome, often informing the missing link between RE and their target genes. Indeed, several KOLs – e.g.,
Dr. Tomi Pastinen calls scATAC, scRNA and scHiC as the “trifecta of modalities” that can truly delineate gene
regulatory programs of individual cells (see Dr. Pastinen’s letter and 30+ additional letters of support).
Recognizing the value, several academic labs have developed scHiC protocols, which has already unraveled
incredibly detailed mechanistic insights of gene regulation of complex microenvironments including breast
cancer, prostate cancer, hippocampus – several of these studies are discussed in this application. Despite the
enthusiasm around scHiC data, adoption has been restricted to a few labs because of (1) severe experimental
inefficiencies that result in exorbitant costs (upwards of $20,000 per sample), and (2) because current scHiC
protocols involve complex plate- or combinatorial indexing workflows that are challenging to setup and execute.
Via a self-funded phase-1 program, we tackled problem (1) to drastically improve efficiency of scHiC and
consequently, drive costs down from earlier $10 per cell, to <$2 per cell, details of which are discussed both in
research and commercial plans. We then used our rigorous product development expertise to translate the
resultant scHiC chemistry into kits that were extensively validated by multiple KOLs (see letters from Joe Ecker,
Longzhi Tan and others). Upon validation, these KOLs have become customers using Arima’s scHiC, referred
to as A-scHiC kits, in their single cell workflows instead of the inefficient former academic protocols. Webinars
and conference presentations from these early adopters created a ripple in the community and in a span of few
months, we have sold >1,000 reactions of A-scHiC kits to tens of academic labs (despite no marketing activity
from Arima), who have embedded our kits within both the plate- and combinatorial indexing single cell workflows.
The scope of phase-2 program is to tackle problem (2) to enable widespread adoption. In particular, we propose
to build off the A-scHiC chemistry toward what we refer to as the sc3DGR chemistry that is performed upstream
of 10X genomics (10XG) Chromium – i.e., the output of sc3DGR kit will be an input into the 10X ATAC (flavor1)
or 10X Multiome (flavor2) kits, to concurrently capture scHiC and scATAC (flavor1), or, scHiC, scATAC and
scRNA (flavor2), respectively. Such a chemistry will not only solve the ease to use problem (2) given its
combability with the market leader 10XG, but importantly, it will enable multiomic analyses of the “trifecta” from
the same individual cell concurrently, thus enabling cell perturbation, characterization and screening use-cases
for precision mapping, diagnosis, and therapy. Once the sc3DGR chemistry is finalized, we translate it into robust
kits, to be validated by 14 KOLs (see letters of support) across academia and pharma (AbbVie, AstraZeneca &
Genentech). For Arima, the chemistry, the informatics, the easy end-to-end workflows, the overall workflow cost,
the KOL-based go-to-market strategy – all play major factors in a seamless commercialization process of this
leapfrog technology for delineating gene regulation programs of individual cells.

Public health relevance
Scalable single-cell workflow for multiomic analyses of chromatin interactions, accessibility, gene expression and cell surface proteins to unravel mechanisms of cellular diversity Arima Genomics Project Narrative Precise regulation of genes is essential for establishing cellular diversity and functionality throughout the human body, and mis-regulation of genes causes human disease. To regulate expression, cells utilize regulatory regions embedded within chromatin, as well as the physical interactions between regulatory regions and genes contained within the three-dimensional (3D) nuclear milieu of each cell. Most genomics assays to study 3D chromatin interactions, including ones developed by Arima, analyze samples in “bulk” – where measurements of chromatin interactions are averaged across all cells in the population, failing to capture the ever-important dynamic chromatin interaction landscape in each cell within a larger tissue or organ system. Lately, academic assays have been developed to analyze chromatin interactions in single cells, but these assays remain inefficient, and complex. Improved and standardized assays are critically needed. Via a self-funded phase-1 project, Arima has overcome these challenges to develop a kit-based solution for efficient mapping of chromatin interactions in single cells. To truly inform gene regulatory mechanisms, chromatin interactions cannot be studied in isolation – instead, it needs to be captured alongside regulatory and gene expression information. Building off the phase-1 kit, Arima proposes to develop a scalable kit-based solution for concurrently mapping all three modalities within individual cells. The development of our new single-cell multiomic solution aims to build new inroads for delineating mechanisms governing cell diversity and function in heterogeneous disease microenvironments, toward ultimately improving the human condition via enhanced discovery, diagnosis, and therapy.